Cell Biology

Project Summary-Cell Biology Core
The OVERALL aims of this Vision Research Core (VRC) are to provide:
• access to resources outside the scope of individual R01 awards
• access to technical expertise outside the scope a single laboratory
• staff training to remove barriers to efficient translational research and collaboration
• collaboration initiatives among VRC labs
The research areas supported by the VRC span the analysis and treatments of retinal degenerations,
developmental disorders, glaucoma and other disorders, as well as a range of cutting-edge basic science
initiatives. We have implemented four resource modules that continue the natural evolution of how this
research group works together, serving 17 investigators holding 22 NEI R01 awards.
The Cell Biology Module derives from the strengths in mouse genetics at the Moran Eye Center and the high
demand for tissue culture and profiling. Almost every JMEC laboratory has need of high quality resources for
cryosectioning, paratoming, genotyping, immunocytochemistry, quantitative PCR (qPCR), cell culturing, and
mouse colony preservation. Some JMEC laboratories will have future need for induced pluripotent stem cell
(iPSC) generation and retinal organoid differentiation.
Specifically the Cell Biology module provides:
• High-quality cryotomy resources through two professionally maintained Leica CM3050S systems
• Paraffin embedding and section services via a Leica Paratome
• PCR and genotyping services
• Training of cryosectioning, immunocytochemistry, genotyping, and qPCR
• Cell culture resources through access to a well-equipped and maintained biosafety level 2 (BSL2) cell
culture facility
• Technical consultation for mouse line cryopreservation, iPSC generation and retinal organoid
differentiation